The role of caspase-3 mediated cleavage of VPS4A in restricting HSV-1

PROJECT SUMMARY/ABSTRACT
Caspases are critical initiators and executioners of programmed cell death (PCD) pathways. While these
pathways function in antiviral defense, little is known about the mechanisms by which caspases and PCD
pathways restrict virus replication. This is particularly true in mucosal barrier tissues, such as the oral cavity
which is the entry site of numerous human pathogens including herpes simplex virus 1 (HSV-1). Recently, we
found that oral epithelial keratinocytes undergo a pro-inflammatory cell death process known as pyroptosis
when treated with activators of the tumor necrosis factor receptor (TNFR)-dependent extrinsic PCD pathway. In
addition, activation of this extrinsic PCD pathway inhibited the replication of a HSV-1 mutant lacking the viral
protein ICP6 (HSV-1 ∆ICP6), which has previously been shown to be unable to inhibit extrinsic cell death in
other cell types. TNFR-mediated restriction of HSV-1 ∆ICP6 in keratinocytes was blocked with the addition of a
pan-caspase inhibitor, implicating a role for caspases in inhibiting this viral mutant. Thus, oral keratinocytes
represent a robust biologically relevant system to study the mechanisms by which caspases restrict virus
replication. We found that several caspases, including caspase-3 and -8, were activated in normal oral
keratinocytes where the TNFR-dependent extrinsic PCD pathway was activated. Further, we found that
restriction of HSV-1 ∆ICP6 under these conditions occurs at a late step in the viral replication cycle (e.g.,
egress). Additional investigation revealed that caspase-3 activation in oral keratinocytes promotes cleavage of
a pool of vacuolar protein sorting 4A (VPS4A), a component of the endosomal sorting complex required for
transport (ESCRT)-III pathway. VPS4A is an AAA-ATPase known to function in HSV-1 egress. Thus, the central
hypothesis of this proposal is that extrinsic cell death activation results in caspase-3-mediated cleavage of
VPS4A, resulting in the formation of a dominant negative protein that inhibits HSV-1 egress. We will investigate
this hypothesis with two distinct aims. In Aim 1, we will define the mechanism and functional consequences of
VPS4A cleavage on HSV-1 replication. In Aim 2, we will determine the mechanism by which TNFR-mediated
extrinsic cell death activation restricts HSV-1 ∆ICP6. Completion of these aims will lead to a better
understanding of the molecular mechanisms by which caspases restrict HSV-1 and fill an important gap in the
field regarding how these proteases function in antiviral defense at barrier tissues.

Public health relevance
PROJECT NARRATIVE Caspases are cellular proteases activated during programmed cell death (PCD) pathways, but their role in antiviral defense remains poorly understood. These studies will elucidate the mechanisms and consequences of cleavage of a novel putative caspase-3 target protein and define its role in antiviral defense in oral keratinocytes. Completion of these studies will provide basic molecular information on how caspases function to protect barrier tissues following viral infection.